3D Immunohistochemistry analysis to enhance the rigor of motoneuronal somatic reconstruction and potassium channel characterization

Abstract/Summary
3D Immunohistochemistry (IHC) analysis to enhance the rigor of motoneuronal somatic reconstruction and
potassium channel characterization. Clinical Relevance: Amyotrophic lateral sclerosis (ALS) has few
therapies with only modest benefits despite decades of research. Barriers arise from complex, multifarious
pathologies and conflicting reports in the ALS literature, often due to inconsistent methods and unaccounted
for biological variables. Parent grant data implicates Kv2.1 and SK potassium ion channels in the excitability
dysregulation of motoneurons (MNs) in ALS, specifically in SOD1-G93A and rNLS8 ALS mouse lines. The
objective of this research is to develop novel 3D IHC analysis methods to rigorously examine somatic
morphology and potassium channel structure in normal vs. diseased states to elucidate the roles of Kv2.1
and SK in ALS. Rationale: Current 2D IHC methods do not provide accurate measures of soma size or ion
channel structure. Also, standard manual tracing to assess 2D area involves human bias. Notably, MN soma
volume indicates vulnerability to ALS (largest cells die first). Also, the soma surface area impacts membrane
capacity for ion channels. Thus, 3D somatic measurements are vital to the parent grant. Also, the multiple,
complex roles of potassium channels in regulating MN excitability, and the fact that these channels are
understudied in spinal MNs, makes rigorous characterization of Kv2.1 and SK critical to the parent grant’s
work. Thus, our Specific Aims are: SA 1) Develop algorithms for accurate 3D reconstruction and
measurement of MN somas in IHC: 2D soma measurements require subjective and tedious manual cell
body tracing, which is sensitive to human error and biased by image orientation. Also, current 3D software-
renderings are low-resolution and insufficient for 3D ion channel quantitation. Thus, the candidate will develop
unbiased algorithms to automatically trace the 3D somatic membrane and quantitate soma volume and
surface area. SA 2) Rigorously characterize somatic potassium channel structure and calibrate
analysis to known channel phosphorylation states in healthy spinal MNs: Kv2.1 and SK structure each
exhibit a structural range from tightly clustered to loosely dephosphorylated depending on their functional
state. These graded clustering changes are not thoroughly characterized by visual inspection, as proposed
in the parent grant. Thus, the candidate will develop quantitation algorithms for 3D intensity maps to
characterize Kv2.1 and SK structure. SA 3) Characterize Kv2.1 and SK structure in ALS spinal MNs: While
Kv2.1 and SK qualitative structural changes have been observed across healthy cell function, both channels
have been understudied in ALS and never characterized in rNLS8 specifically. Thus, we will rigorously
characterize Kv2.1 and SK clustering changes in rNLS8 MNs and compare/contrast these changes to those
measured in SOD1 MNs. Completion of these studies will link potassium channel structure changes to
functional changes in both SOD1 and rNLS8 MNs, thus elucidating Kv2.1 and SK’s role in ALS.

Public health relevance
Project Narrative This proposal is relevant to public health because ALS has few therapies with only modest benefits despite decades of research. Barriers arise from multifarious pathologies and conflicting literature, often due to inconsistent methods and unaccounted for biological variables. This project will develop advanced 3D quantitation of immunohistochemistry images to rigorously examine somatic morphology and potassium channel structure in normal vs. ALS motoneurons, to elucidate pilot data from the parent grant suggesting that Kv2.1 and SK contribute to functional changes in ALS.